GUMC Zebrafish Shared Resource Aquatic Habitat Modernization Project

Abstract: The Georgetown University Medical Center (GUMC) Zebrafish Shared Resource (ZSR), a member
of the Lombardi Comprehensive Cancer Center (LCCC) Research Consortium, provides expertise and ready
access to zebrafish as a model for biomedical research to the GUMC community. Under the direction of Dr.
Eric Glasgow, Assistant Professor of Oncology, and with assistance from Dr. Matthew Swift, the ZSR has
provided research services and support for dozens of investigators, both internal and external, to incorporate
zebrafish models into their research. The ZSR was the first of its kind to offer full-service access to zebrafish
models anywhere and is an essential part of GUMC fulfilling its mission to offer a full range of state-of-the-art
research services expected of a top national academic medical center. The current aquatic life support system
utilized by the facility was built in 2004. Due to maintenance by and expertise of the ZSR director, the facility
has far outlasted its projected useful lifespan, as well as that of the company that built it, Aquatic Habitats. A
complete upgrade of the current system is necessary in order to maintain and enhance the efficiency and
standardization of our zebrafish husbandry. A modern, technologically advanced aquatic animal system
equipped with water quality assessment sensors will increase the housing capacity, doubling the number fish;
decrease the husbandry workload increasing operational efficiencies; increase sustainability by saving energy,
water, and materials; standardize husbandry conditions; and improve the consistency and quality of egg laying.
These improvements will increase research capacity of the ZSR, as well as improving the rigor, reproducibility,
and translatability of our zebrafish-based research. We are applying for this R24 grant in order to purchase a
new aquatic system that will accomplish these goals and allow GUMC to expand on its position as one of the
leaders in utilizing the zebrafish model for research into oncology, immunology, neuroscience, and
developmental biology. If awarded, the grant will cover necessary expenditures related to the purchase of the
new system and required support equipment.

Public health relevance
Project Narrative: This application will support the purchase of a new aquatic habitat to replace the current outdated and aging facility at the Georgetown University Medical Center, Zebrafish Shared Resource. Zebrafish models have become a crucial component of modern research programs aiming to cure cancer and neurological maladies. The upgraded and modernized habitat will ensure the continued high level of rigor, reproducibility, and translatability of our zebrafish-based research having major and positive impacts on a significant number of NIH funded projects.